Core B - Fieldwork and Data Core

Core B: Fieldwork and Data Core—Abstract
Valid, reliable, and comparable data are an essential component of effective public health programs. The goals
of Core B of the Health, Aging and Dementia in South Africa: A Longitudinal Study (HAALSI) Program
are to establish rigorous, standardized systems of collecting, managing, analyzing, and disseminating data, as
well as to harmonize systems across surveys in the Agincourt community site and at national sites. These
surveys collect data on socioeconomic measures, health, well-being, and cognition and will be the central
source of data for achieving the aims of the Program. To meet these goals, Core B will: (1) Adapt and
implement measures and methods for field data collection; (2) Ensure collection of high-quality data through
the use of existing protocols and rigorous quality control measures for all project data; (3) Manage datasets
and provide analytic support; and (4) Sample, maintain, and track the cohort. Fulfilling these aims will require
close collaboration between partners at the University of the Witwatersrand (Wits), the Southern Africa Labour
and Development Research Unit (SALDRU) at the University of Cape Town (UCT), and the Harvard Center for
Population and Development Studies (HCPDS), as well as coordination with Core A on public data release and
Core C on proper biomarker data collection and interpretation. Core B will work closely with PIs from each
project to meet data and analytic needs. The work in Core B will benefit from the extensive experience of the
research team in the implementation and analysis of complex surveys.